Neurofilament regulation of sensory neuron axon caliber

PROJECT SUMMARY
The cross-sectional diameter, or caliber, of axons and dendrites varies dramatically (>100 fold). Caliber
influences the electric properties of neurites, their capacity for intracellular trafficking, and their vulnerability to
damage. Many branching neurite arbors have tapering calibers: The primary branch is the thickest and each
higher branch order is successively thinner. Although intense efforts have focused on studying mechanisms of
neurite outgrowth, branching, guidance, and synapse formation, much less attention has focused on the
regulation of neurite caliber. One reason for the relative lack of attention to caliber is that it is difficult to
measure with light microscopy. Relatedly, although much effort has focused on understanding how
microtubules and actin filaments contribute to neuronal structure, the third major cytoskeletal components of
neurons, neurofilaments (NFs), have been relatively neglected. NF abundance correlates with axon caliber,
and NF deficiency reduces average axon caliber, but it is not known if NFs contribute to neurite tapering. The
goals of this project are to establish a zebrafish model for studying axon caliber regulation in vivo, create tools
to study NF distribution and function in zebrafish, and use those methods and tools to determine if NFs
contribute to axon tapering. These studies use a new method to label single zebrafish sensory neurons, called
Rohon-Beard (RB) neurons, in live larvae and measure the caliber of their peripheral axons using super-
resolution microscopy. Preliminary experiments confirm that axon caliber tapers in RB peripheral axon arbors.
Unexpectedly, tapering at the first branch point is usually asymmetric: the primary branch gives rise to one
thick and one thin secondary branch. Aim 1 of this proposal uses live imaging to determine how microtubule
dynamics, intracellular trafficking, and axon structure are affected by caliber asymmetry. Aim 2 uses a novel
strategy is to make fluorescent reporters for endogenous NF proteins and use them to document the
distribution of NFs in peripheral arbors of RB neurons. Aim 3 characterizes the effect of NF deficiency on the
tapering morphology of RB neurons. Collectively, these studies will establish zebrafish as a powerful new
model for studying axon caliber regulation and NF function, and test the hypothesis that NF distribution
regulates neurite tapering.

Public health relevance
PROJECT NARRATIVE The cross-sectional diameter, or caliber, of the axons and dendrites that neurons use to communicate with one another, determines their fundamental properties, including the efficiency with which they transmit signals. Cytoskeletal elements called neurofilaments (NFs) regulate neurite caliber, but it is not known if they are responsible for differences in caliber between branches of the same neurite. This proposal develops a larval zebrafish model to study neurite caliber in live animals, and uses this model to determine if the differential distribution of NFs determines differences in caliber within a neurite.